A novel digital platform for measurement-based peer supervision of non-specialist providers conducting brief psychological interventions

PROJECT SUMMARY
Unmet mental health needs continue to be a significant public health challenge in the US and the
increase in reported adverse mental health conditions associated with the onset of the Covid-19
pandemic have likely exacerbated this problem. We propose a reverse innovation solution to
digitize an evidence-based task sharing approach for treating depression in individuals from
underserved communities, where health inequities are most pronounced due to a shortage of
mental health specialists and lack of access to resources. The digital platform will be designed to
host a suite of tools to support measurement-based peer supervision (MBPS), which includes the
ability for non-specialist providers (NSPs) to record therapy sessions, rate sessions using a
validated quality scale, and review ratings safely and securely with peers in moderated group
discussions. Target end users will be NSPs who are trained on a behavioral activation program
which has been successfully implemented in India to treat depression. The goal of this Phase I
project is to demonstrate acceptability and feasibility of the proposed digital solution. We will
address this goal with two specific aims. In Aim 1, we will work in close collaboration with experts
in MBPS and an advisory group of NSPs to determine design requirements and develop a
prototype of the digital solution. In Aim 2, a purposive sample target end users (i.e., NSPs trained
in behavioral activation) will test the prototype developed in Aim 1. We will use mixed methods
(interviews, surveys, passive usage data) to probe usability and user experience and identify
barriers and facilitators to implementation. Results from Phase I will inform a potential Phase II
project to study the digital platform’s implementation at scale and its effect on NSP performance
with the long-term goal of improving mental health outcomes, particularly in hard-to-reach
communities that can benefit the most from NSP-led support.

Public health relevance
PROJECT NARRATIVE There is an urgent demand for mental health services in the US, particularly in communities with limited access to mental health specialists and resources and increasing incidence of depression. The goal of this Phase I SBIR project is to design, develop, and assess the feasibility and acceptability of a scalable digital solution to support and augment the work of non-specialist providers (NSPs) such as community health workers or peers in recovery from mental health conditions tasked who are delivering evidence-based brief psychological interventions to individuals experiencing symptoms of depression. The proposed suite of digital tools will be expressly designed to promote quality assurance and NSP skill development, while also serving as a critical support system for NSPs themselves, with the goal of ultimately improving quality of care and mental health outcomes.